Antemortem biomarkers in nasally exhaled breath: A potential novel, noninvasive human diagnostic technique for Alzheimer’s Disease

ABSTRACT
The goal of this proposal is to test the hypothesis that nasally exhaled breath contains biomarkers of
Alzheimer’s disease (AD). Preliminary data from our lab indicate that: (1) the neural protein Tau is
present in nasally exhaled breath at higher concentrations than in orally exhaled breath, and (2) Tau
concentration increases linearly with dementia severity in patients with AD. An established body of
research indicates that exhaled breath contains a rich variety of biological molecules including proteins,
cytokines, RNA, DNA and other biomarkers that originate along the lining of the respiratory tract. With the goal
of measuring respiratory biomarkers, the vast majority of exhaled breath studies use orally exhaled breath; by
contrast, very little research has focused on nasally exhaled samples. In this proposal, we aim to focus our
research on nasally exhaled breath in order to test the hypothesis that the unique anatomy of this exhalation
route provides direct access to neural biomarkers of AD. Specifically, human olfactory sensory neurons
constitute the only part of the central nervous system that makes direct contact with the external environment.
The cilia on their peripheral ends protrude from the olfactory mucosa into the nasal cavity, while the central
ends project through holes in the cribriform plate at the base of the skull and synapse directly onto the brain.
The human cribriform plate is also a drainage pathway for cerebrospinal fluid. As a result of these unique
anatomical circumstances, chemical constituents of the central nervous system are present in the olfactory
mucosa inside the nose, likely due to nasally exhaled air flowing turbulently over the olfactory mucosa and
volatilizing proteins in this region. In this proposal, we aim to explore the novel idea that these volatilized neural
proteins can be collected in nasally exhaled breath and quantitated. To test this notion, we will first examine
the hypothesis that biomarkers of neurological disease (Tau, beta-amyloid) can be quantitated noninvasively
by collecting nasally and orally exhaled breath from patients currently diagnosed with AD, and comparing
levels of biomarker concentration across nasal and oral samples. Second, we will compare levels of
biomarkers concentration (nasal, oral) across three groups of participants: patients with AD, age-matched
healthy controls, and healthy young adults. Across the proposed experiments, we will also look for correlations
between nasally (vs. orally) exhaled proteins and disease severity. If successful, results from the proposed
studies could aid in the development of a novel, noninvasive and inexpensive diagnostic tool for ADRD and
other neurological diseases that could offer mobility and accessibility for at-home testing. Future research in
this direction would not only be clinically valuable but could also leave a broader scientific impact by initiating a
step forward in advancing current limits of real-time human brain chemistry measurement.

Public health relevance
The discovery of neural proteins in nasally exhaled breath has the potential to lead to a new noninvasive tool to measure biomarkers of Alzheimer’s Disease and Related Dementias (ADRD). Such a tool would lower barriers to use, carrying numerous public health benefits, including aiding in the diagnosis of early disease states, reducing patient discomfort, and potentially contributing a unique new set of neurological biomarkers. This research may also shed light on the mechanistic basis for the early onset of olfactory symptoms in ADRD.